Phase separation of nuclear tau and its role in gene regulation

Project summary
Tau is a microtubule-associated protein found in neurofibrillary tangles in the brains of Alzheimer’s disease
patients. Tau can form amyloid fibrils both in vitro and in vivo and can undergo liquid-liquid phase separation in
the presence of crowding agents and nucleic acids. While much of tau research has focused on its microtubule
associated functions and aberrant aggregation in the context of Alzheimer’s disease, tau is also found in the
nucleus. Mounting evidence has suggested that nuclear tau might play a role in DNA protection, chromosome
stability, and heterochromatin formation although the molecular mechanisms behind these functions have
largely remained enigmatic.
Tau’s presence in heterochromatin is especially intriguing, since it localizes to an
environment where it would be predicted to phase separate, with other proteins known to do so. Therefore, in
this exploratory proposal,
we aim to test a hypothesis that tau might play a role in heterochromatin regulation
through a phase separation mechanism. We also hypothesize that aberrant phosphorylation and disease-
relevant mutations may disrupt this process and may lead to compromised cellular ability to regulate gene
expression. We propose to test these hypotheses through in vitro biophysical and structural assays, coupled
with cell-based experiments designed to gain better understanding of the potential functions and biophysical
properties of nuclear tau. We aim to provide a new viewpoint regarding the molecular mechanisms behind
Alzheimer’s disease that is distinct from the amyloid hypothesis and hope to inform the development of new
therapeutic and diagnostic approaches.

Public health relevance
Project narrative Tau is a microtubule-associated protein found in neurofibrillary tangles in the brains of Alzheimer's disease patients. While tau research has been primarily focused on its cytoplasmic function and on its ability to form amyloid fibrils, tau is also found in the nucleus where it may play a role in gene regulation. Here, we explore the potential role of nuclear tau and investigate how Alzheimer’s disease-relevant forms of tau might disrupt gene silencing, thus leading to far reaching consequences for normal cell function and disease.